MULTICOMPARTMENTAL ANALYSIS OF CALCIUM METABOLISM

Abnormal calcium metabolism in adolescent children and postmenopausal women can have devastating consequences. The objective of this study is to elucidate the kinetics of calcium metabolism in normal children and to evaluate disease related changes in calcium metabolism in children and adults. Stable calcium isotopes were administered to children and women of childbearing age and serial samples were obtained for two to four days. Two stable isotopic tracers were used in these studies; one given orally and one given intravenously. The use of two tracers allows direct measurement of several important parameters of calcium metabolism, principally the fraction of calcium absorbed orally and the endogenous fecal excretion. Thermal ionization isotope ratio mass spectrometry was used to measure tracer enrichments in serum, urine, feces and food. The data was used to develop a multicompartmental model of calcium metabolism that better characterized calcium metabolic fluxes between regions of the body.